High-throughput Identification of Non-hallucinogenic Psychoplastogens for Treating Addiction

PROJECT SUMMARY/ABSTRACT
Pathological changes in neural circuitry underly a variety of neuropsychiatric diseases including addiction and
depression. Accumulating evidence from human imaging, postmortem analysis, and animal models suggests
that atrophy of neurons in the prefrontal cortex (PFC)—including the retraction of dendritic arbors, loss of
dendritic spines, and reduction in synapse density—plays a key role in the pathophysiology of substance use
disorders (SUDs). The PFC is well known to regulate limbic reward circuitry, modulate attention, and exert top-
down control over drug-seeking behavior, and thus, the atrophy of neurons in the PFC is believed to worsen
SUD by reducing executive control, exacerbating impulsivity, and leading to deficits in the extinction of drug-cue
memories. Therapeutic strategies aimed at restoring PFC structure/function are hypothesized to have broad
therapeutic potential for SUDs. Psychoplastogens—small molecules that activate TrkB signaling and serve as
brain-derived neurotrophic factor (BDNF) mimetics—are able to rapidly restore functional connectivity in the PFC
and produce long-lasting therapeutic effects after a single administration. However, the most prominent
psychoplastogens—including serotonergic psychedelics—all produce hallucinations, which greatly limit their
therapeutic potential. Recently, evidence has emerged suggesting that the hallucinogenic effects of these drugs
may not be necessary for their therapeutic properties, and the first non-hallucinogenic psychoplastogens were
introduced by our group this past year. One such molecule, known as tabernanthalog (TBG), produces both
rapid and sustained anti-addictive effects in rodent models of heroin self-administration, much like the known
anti-addictive psychedelic ibogaine. The advent of TBG represents an exciting new direction for the treatment
of addiction, but there is an urgent need to develop new assays enabling the rapid identification of TBG-like
molecules with optimized efficacy and safety profiles. Our overall objective is to develop high-throughput
methods for identifying non-hallucinogenic psychoplastogens that, like TBG, can produce long-lasting
therapeutic effects. To achieve this goal, we have developed psychLight—a genetically encoded, 5-HT2AR-
based biosensor capable of predicting both the hallucinogenic and psychoplastogenic properties of small
molecules. The proposed studies involve the use of this technology to rapidly identify new non-hallucinogenic
psychoplastogens for treating addiction as well as probing potential 5-HT2AR interactions with dopamine, opioid,
and cannabinoid receptors. We also propose studies to elucidate the molecular and circuit-level mechanisms of
the anti-addictive, non-hallucinogenic psychoplastogen TBG. Ultimately, the work described here will fill the gap
in our knowledge about how best to rapidly screen for non-hallucinogenic psychoplastogens, which will enable
the rational design of safer, non-hallucinogenic alternatives to psychedelics for treating SUDs and related co-
morbid diseases such as depression.

Public health relevance
PROJECT NARRATIVE Compounds that promote neuroplasticity, such as serotonergic psychedelics, have enormous potential for treating a variety of neuropsychiatric diseases including addiction. Recently, our group discovered that it is possible to engineer non-hallucinogenic analogs of psychedelics capable of promoting neuroplasticity and producing sustained antiaddictive effects after a single administration. The research described here seeks to develop high-throughput methods for identifying such compounds with the ultimate goal of developing new treatments for substance use disorders.